MODULATION OF THE EXPRESSION OF A MULTIDRUG RESISTANCE GENE

The focus of the laboratory continues to center around the problems of drug resistance. As in the past, three major areas continue to be actively investigated. They are: multidrug resistance mediated by P-glycoprotein, adriamycin resistance associated with overexpression of a 95 kilodalton membrane protein and mechanisms of cisplatin resistance.